Liquid Chromatography - Triple Quadrupole Mass Spectrometer System

Project Summary
St. Mary's University is a Hispanic Serving Institution (HSI) located in San Antonio, TX, with 41%
of undergraduates being supported by Pell Grants over the last 3 years. St. Mary's has a strong
history of preparing students for successful careers in the biomedical sciences. To enhance the
research and educational biomedical training of undergraduates in the Department of Chemistry
and Biochemistry at St. Mary's, a liquid chromatograph – triple quadrupole mass spectrometer
system (LC-MS/MS) is requested. Triple quadrupole LC-MS/MS is the gold standard for small
molecule analysis, peptide and protein analysis, and metabolomics. The requested instrument is
a Thermo Scientific Vanquish Core with TSQ Fortis and Chromeleon software. This robust
system provides superior selectivity and sensitivity for analytical applications. The primary
educational activities will be in Biochemistry and Analytical Chemistry courses, while also being
incorporated into Instrumental Analysis, Forensic Chemistry, Enzyme Chemistry, Medicinal
Chemistry, and Environmental Chemistry courses. Research activities focus on using the LC-
MS/MS system to characterize self-assembled co-ordinate complexes, metabolic profiling, and
small molecule analysis. The proposed instrumentation has the strong support of the institution,
including support for infrastructure, supplies and maintenance.

Public health relevance
Project Narrative The goal of this project is to enhance the research and educational biomedical training of undergraduate students at St. Mary's University through the acquisition of a liquid chromatograph – triple quadrupole mass spectrometer system (LC-MS/MS). This state-of-the-art instrument will be used in the classroom and laboratory for small molecule and peptide analysis, and targeted metabolomics. The requested instrument is a Thermo Scientific Vanquish Core with TSQ Fortis and Chromeleon software.